Chronic Critical Illness in the United States

DESCRIPTION (provided by applicant): The chronically critically ill are a vulnerable population of patients with persistent multi-organ failure; they represent the sickest-sick. This population, although small, is increasing in number; they present a significant burden to intensive care infrastructure and are expensive to care for. The current state of the medical literature for the chronically critically ill population is limited to small cohorts from individua tertiary care hospitals; national estimates for the epidemiology, outcomes and costs of this population are needed to inform policy making and resource allocation in the future. I propose to create a definition of chronic critical illness for use in administrative datasets. I will describethe population both in cross-section and over time using two nationally representative datasets. I will then identify the burden of pre-morbid disease, describe outcomes and estimate costs. I additionally propose to use a novel device to capture body composition at the time of intensive care unit admission to predict progression to chronic critical illness and ultimately provide bette prognostic information to patients and their caregivers to aid in resource allocation and determination of goals of care.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic critical illness, a state of prolonged multi-organ failure requiring ongoing and intensive medical care, is increasing in prevalence in the United States but the absolute size of this population, as well as the costs and outcomes associated with this condition, are largely unknown. Precise epidemiological estimates, as well as trends over time, for this vulnerable population will be invaluable to inform our ongoing and important national conversation about allocation of healthcare resources.